Summer Undergraduate Research Internship Program

ABSTRACT
The long-term goal of the proposed University of North Texas Health Science Center's Summer
Undergraduate Research Internship Program (SURIP) is to increase the number of students from
underrepresented minority groups, individuals with disabilities and those from disadvantaged backgrounds into
biomedical and behavioral science careers. Over the last five years, a diverse and motivated cohort of
undergraduate trainees experienced hands- on training, didactic enrichment, and networking, emphasizing
research careers in substance abuse and addiction research. This renewal application will build upon best
practices and lessons learned to broaden access to 1) an inclusive and culturally aware environment 2)
resources for trainees to participate in cutting-edge research that complement the mission of NIDA (e.g.,
students, infrastructure, and programs); and 3) mentoring excellence and mentoring networks for applying to
and making decisions of graduate schools. The expected impact is a sustainable program that leads to trainees
from diverse backgrounds enter graduate research programs, leading to biomedical research careers.

Public health relevance
NARRATIVE This program will address the significant gap in the number of underrepresented minority groups, disadvantaged populations and individuals with disabilities that enter biomedical and behavioral science careers. This program will provide undergraduate students interested in pursuing NIDA-related research, a 10- week summer research experience in a mentor-guided laboratory. The expectation is an increase in the number of diverse and highly motivates students attaining biomedical degrees in the biomedical and behavioral sciences.